Functional Studies of "Deafness Genes" Essential for Hearing

One remaining project is being completed on the functions of MYO15 in stereocilia development and long term maintenance (Moreland et al 2023 Nature Communications, under revision). We are also continuing to pursue studies of mouse models of human deafness genes that have been identified in the LMG. At least two of the three major isoforms of TRIOBP (TRIOBP-4 and TRIOBP-5) are necessary for normal hair cell stereocilia rootlet formation and the maintenance of stereocilia rootlets in the adult organ of Corti. Rootlets provide bundle stiffness necessary for the detection of sound. The function of TRIOBP-1, if any, in the auditory system has not been reported and is being examined using a floxed exon 1 of mouse Triobp. Similar strategies will be used to study in mouse the functions of genes necessary for hearing in human that are identified from genetic analyses of large families segregating deafness. These genes presently include LRP2, MAP3K1 and ADAMTS.